THE EFFICACY OF PRISM ADAPTATION IN ACQUIRED ESOTROPIA

Retrospective studies indicate that only 50% of surgical patients with acquired esotropia achieve good eye alignment with one surgery. New evidence indicates that with the preoperative use of prisms, good eye alignment can be achieved with one operation in approximately 85% of surgical patients with acquired esotropia. A multicenter, randomized, prospective, clinical trial with careful attention to standardization and unbiased outcome evaluation is proposed to determine if: 1. The surgical result in patients with acquired esotropia is better if they have preoperative prism adaptation than if they do not have preoperative prism adaptation. 2. If those patients who respond to prism adaptation are more accurately corrected by operating for the prism adapted angle or the original angle of deviation. 3. If there are clusters of input variables, (e.g. age, size of deviation, sensory status, refractive error, or AC/A ratio) that help to predict which patients are more likely to respond to the prism adaptation test. In an effort to answer these questions a double randomization study has been designed. Two-thirds of the patients will be randomly selected to go through prism adaptation prior to surgery. One-third of the patients will have surgery based on the amount of crossing measured using routine examination techniques. Of those patients who respond to the prisms, one-half will have surgery based on the amount of prism required to stabilize the deviation while the rest will have surgery based on the amount of crossing originally measured. If prism adaptation does lead to more successful surgery, its adoption can have a significant effect in meeting the long term objective of decreasing the cost and morbidity for the treatment of acquired esotropia. Approximately 2,500 reopertions for acquired esotropia are performed each year in the United States. If these could be reduced by two thirds through utilization of prism adaptation with each operation costing between $2,000 and $3,000 (hospital cost + physician's fees), the total dollar saving would be between $3.2 million and $4.8 million per year. Morbidity would likewise be reduced, with proportionally fewer operative complications occurring, less time lost from school and work, and considerably less psychological trauma on the part of the patient, the family, and the physician.